RECOMBINANT HUMAN NERVE GROWTH FACTOR FOR THE TREATMENT OF HIV INFECTION

The purpose of the study is to evaluate the safety, tolerability, and efficacy of recombinant human nerve growth factor (rhNGF) in ameliorating HIV sensory neuropathy and the associated pain.